Striatal Function in Psychosis Relapse

PROJECT SUMMARY
Psychotic disorders are often characterized by recurrent relapses over the course of illness. Relapses impact
occupational and social functioning, may endanger the patient and others, and often require inpatient
hospitalization, driving up healthcare costs. In fact, the cumulative effect of relapses plays a major role in the
quality of life of individuals with psychotic disorders in the long run. The pathophysiology of psychosis relapse
has not been well captured in most previous research, as few studies account for the confounder of
antipsychotic drug non-adherence, which affects most patients with psychosis at some point during treatment
and is often unnoticed. In this proposal, we aim to study the neurobiological mechanisms of psychosis relapse
in individuals treated with long acting injectable (LAI) antipsychotics, for whom medication adherence at the
time of relapse can be reliably quantified. We will focus on striatal functioning, given its critical role in the
pathophysiology of psychosis and as a target of antipsychotic drugs. Specifically, we will conduct MRI
assessment of striatal functioning at rest (Aim 1) and during reward processing (Aim 2), as well as of meso-
striatal dopamine transmission using neuromelanin sensitive MRI (Aim 3). We will compare these measures in
a cross-sectional design between individuals with psychosis relapse during treatment with LAI antipsychotics
(n=44), individuals who are symptomatically stable during treatment with LAI antipsychotics (n=44) and healthy
controls (n=32). Our general hypothesis is that individuals experiencing relapse will show greater degree of
aberrant striatal functioning compared with clinically stable individuals on LAI treatment. If successful, this
project will generate data about the pathophysiology of psychosis relapse unbiased for treatment adherence.
Such data are critical to develop much needed prognostic biomarkers for relapse prevention in psychosis.

Public health relevance
PROJECT NARRATIVE Symptom relapse is quite common in the course of illness of schizophrenia, yet its pathophysiology has not been well captured in most previous research, as few studies account for the common confounder of treatment non-adherence. In this proposal, we aim to study brain functioning in individuals treated with long acting injectable antipsychotics at the time of relapse, for whom medication delivery can be confirmed. The results from this study will generate knowledge about the essential brain mechanisms of psychosis relapse despite confirmed medication delivery.